Gene regulation and social relationships across the life course in a nonhuman primate model

Project Summary
Social support and social integration are some of the most robust predictors of morbidity and mortality
identified to date. This relationship arises from increased susceptibility to several of the top causes of death in
the United States, including major diseases of aging such as heart disease and cancer. Recent studies
suggest that a signature of social relationships is also detectable in data on gene regulation, highlighting a
potential pathway through which social ties get “under the skin” to influence health. However, despite abundant
evidence that the health effects of social relationships begin early in life, no studies have related the full life
course trajectory of social relationships to data on gene regulation, or used these data to investigate why some
individuals appear more susceptible to social isolation than others.
The goal of this study is to address these gaps by linking fine-grained, longitudinal data on social
relationships to unbiased surveys of the molecular signature of social experience. To do so, we will leverage
an established model for social relationships and health in natural animal populations, the baboons of the
Amboseli ecosystem of Kenya. This population has been the subject of longitudinal study for up to 9
generations, revealing that social isolation predicts shortened lifespan in a manner highly analogous to
humans. We propose to link annual measures of social relationships, from birth through adulthood, with gene
expression and chromatin accessibility data collected both at baseline and following ex vivo challenge with
bacterial and viral mimics. This strategy will allow us to investigate the types of social relationships that matter
most, the timing of their effects on gene regulation, and their relevance for immune function, a primary
contributor to variation in health during aging.
Using these data, we will address three aims. First, we will characterize the gene regulatory signature of
variation in social relationships across the life course. We will investigate the relative roles of early life,
cumulative experience, and social relationships close to the time of biological sample collection, as well as the
relative importance of social relationship quantity versus quality. Second, we will assess whether individuals
vary in their sensitivity to social environments based on genotype, by identifying gene-social relationship
interactions that affect gene expression. Finally, we will test the consequences of social relationship-associated
gene regulation for immune defense and lifespan. In doing so, this work will shed important light on whether
gene regulatory signatures of social relationships are likely to be mechanistically implicated in the link between
social relationships and health, or instead serve as passive biomarkers. Together, our results will provide the
most comprehensive window into the functional genomic signature of social relationships available to date. By
revealing when, how, and for whom social relationships matter most, they will therefore address three
questions of outstanding importance to understanding the role of the social environment in human health.

Public health relevance
Project Narrative Social relationships are some of the most robust predictors of human health and mortality risk known to date. This project investigates how their dynamics across the life course are reflected at the molecular level, by combining a powerful animal model for human social behavior with genomic analyses of gene expression in the immune system. By studying the types and timing of the social ties that matter most, and by linking gene expression data with information on immune function and lifespan, this work will provide important insight into the mechanisms that connect social relationships to health, disease risk, and survival.